Vestibulodynia: Understanding Pathophysiology and Determining Appropriate Treatments (Vestibulodynia: UPDATe)

ABSTRACT
Vestibulodynia (VBD) is a chronic pelvic pain condition that affects 1 in 6 reproductive aged women, yet remains
ineffectively treated by standard trial-and-error approaches. Our group has identified two distinct VBD subtypes
that may benefit from different types of treatment: 1) VBD peripheral (VBD-p) subtype characterized by localized
pain specific to the vulvar vestibule, and 2) VBD central (VBD-c) subtype characterized by pain at both vaginal
and remote body regions. Preliminary data further demonstrate that VBD-p and VBD-c subtypes differ with
respect to patient reported outcomes (e.g., physical and mental health), production of cytokines (intracellular
proteins that regulate the activity of pain nerves and inflammatory processes), and expression of microRNAs
(small non-coding RNA molecules that regulate gene expression). Women with VBD-p exhibit normal
psychological profiles; balanced circulating pro- and anti-inflammatory cytokines; and dysregulation in
microRNAs that regulate the expression of genes in estrogen pathways. In contrast, women with VBD-c report
decreased functional status and increased somatization; increased pro-inflammatory but not anti-inflammatory
cytokines; and dysregulation in microRNAs that regulate the expression of genes relevant to muscle, nerve, and
immune cell function. Based on these data, we hypothesize that two VBD-p and VBD-c subtypes will
preferentially respond to peripheral, central, or combined treatments and can be distinguished by cytokine and
microRNA profiles. These hypotheses will be tested in a phase III clinical trial that evaluates diverse treatment
strategies in women with VBD-p and VBD-c. Participants will be randomly assigned to one of four parallel arms:
peripheral treatment with 5% lidocaine + 0.5 mg/ml estradiol compound cream, 2) central treatment with the
tricyclic antidepressant nortriptyline, 3) combined peripheral and central treatments, or 4) placebo. The treatment
phase will last 4 months (with a 6-week titration at treatment initiation and 2-week taper period at 4 months), with
outcome measures and biomarkers assessed at 4 time points (0, 2, 4, and 6 months). First, we will compare the
efficacy of treatments in alleviating pain among women with VBD-p and VBD-c using standardized tampon
insertion with a numeric rating scale and self-reported pain on the McGill Pain Questionnaire. Next, we will
compare the efficacy of treatments in improving perceived physical, mental, and sexual health among women
with VBD-p and VBD-c using standardized questionnaires. Finally, we will measure cytokines and microRNAs
in women with VBD-p versus VBD-c using multiplex assays and RNA sequencing, and determine the ability of
these biomarkers to predict treatment response. Successful completion of the proposed work will provide new
insights into the mechanisms that drive pain perception and treatment response in two distinct VBD subtypes, and
determine the efficacy of peripheral, central, and combined therapies in reversing this pain. Such findings will readily
translate to improved patient care, permitting the millions of women with VBD, their partners, and clinicians to make
more informed decisions about pain management.

Public health relevance
PROJECT NARRATIVE Vestibulodynia (VBD) is a complex chronic vulvar pain condition that impairs the psychological, physical, and sexual health of 1 in 6 reproductive aged women in the United States. Here, we plan to conduct a randomized, double-blinded, placebo-controlled clinical trial to 1) compare the efficacy of peripheral (lidocaine/estradiol cream), centrally-targeted (nortriptyline), and combined treatments in alleviating pain and improving patient- reported outcomes and 2) determine cytokine and microRNA biomarkers that predict treatment response in women with distinct VBD subtypes. Positive findings from this study will readily translate to improved patient care, permitting the millions of women with VBD, their partners, and their clinicians to make more informed decisions about pain management.